An emerging Alzheimer's disease risk factor: An investigation of hearing impairment, hippocampal function, and memory in middle-aged and older adults

PROJECT SUMMARY
The purpose of this proposal is to investigate the association between hearing impairment and
hippocampal function, and how this association relates to memory function, in cognitively normal middle-aged
and older adults. Hearing impairment has been identified as a modifiable risk factor for Alzheimer’s disease
and dementia, however the mechanism for this is unknown. The central hypothesis in this proposal is that
hearing impairment is associated with poorer hippocampal function and memory, and that differences in
memory are mediated by hippocampal function. This hypothesis is informed by the current literature, which
shows reduced hippocampal volume in humans and reduced plasticity in animal models with impaired hearing.
However, the relationship between hippocampal function and hearing impairment in humans has not yet been
explored. Aims 1 and 2 of this proposal will use data from the UK Biobank to investigate the association
between hearing impairment and hippocampal activity, and their relationship with memory. The dataset
includes: 1) hearing ability categorized into impaired and unimpaired; 2) functional MRI of hippocampal
activation; and 3) memory performance assessed by a Paired Associates task. There is also evidence from
animal models to suggest that hearing impairment and Alzheimer’s pathology may exert a compounding effect
on hippocampal function, but this also has not been examined in humans. Therefore, Aim 3 will collect pilot
data to examine associations between hearing impairment, fMRI hippocampal activation, amyloid-beta
deposition, and memory performance in 30 cognitively normal older adults. The findings from this work will
provide critical evidence for existing theories on the association between hearing impairment and dementia risk
and will inform future hearing-based interventions. Importantly, this work will highlight the need to treat hearing
impairment as part of a comprehensive approach to reducing Alzheimer’s disease risk.
The Principal Investigator, Dr. Megan Fitzhugh, is currently a postdoctoral scholar at the University of
California San Diego (UCSD). Previously, she conducted studies investigating sex differences in the
association between hearing impairment and dementia risk, and studies of longitudinal changes in brain
volume and functional connectivity associated with hearing impairment. Her career goal is to become leading
investigator at the intersection of auditory neuroscience and Alzheimer’s disease, focusing on risk factors of
Alzheimer’s disease, such as hearing impairment. Toward this goal, Dr. Fitzhugh’s career development efforts
during this award will be dedicated toward four areas: advanced statistical methods, audiology, Alzheimer’s
disease and dementia, and mentorship. UCSD is an ideal location for career development due to the expertise
and multidisciplinary nature of the Department of Neurosciences and its associated Shiley-Marcos Alzheimer’s
Disease Research Center and the Alzheimer’s Disease Cooperative Study. This proposal will position the PI to
begin an independent research career and successfully submit an R01 proposal in a faculty position.

Public health relevance
PROJECT NARRATIVE Hearing impairment, a highly prevalent condition in older adults, has been identified as a major, modifiable risk factor of Alzheimer’s disease and dementia. The findings from this study will provide critical yet currently absent knowledge on the relationships between hearing impairment, hippocampal function, and memory performance in cognitively normal middle-aged and older adults. Importantly, this work will inform future hearing-based interventions and will highlight the need to treat hearing impairment as part of a comprehensive approach to reducing dementia risk.